Nicotinamide riboside supplementation for treating arterial stiffness and elevated systolic blood pressure in patients with moderate to severe CKD

PROJECT SUMMARY
This application is in response to NOT-AG-22-025, Alzheimer’s-focused administrative supplements for NIH
grants that are not focused on Alzheimer’s disease (AD). Mild cognitive impairment (MCI), characterized by
reductions in episodic memory, executive function, and other domains of fluid cognitive function beyond
what is expected with normal aging, predisposes individuals to age-related neurodegenerative diseases,
including Alzheimer’s disease (AD) and related dementias. Individuals with chronic kidney disease (CKD)
are at high risk of MCI, with a prevalence approximately 2x the age-matched general population. The risk for
MCI in CKD is in part mediated by large elastic artery (i.e. aortic) stiffness and increased systolic blood
pressure (SBP), contributing to reductions in cerebral vascular function (e.g., increased pulsatile blood
flow and reduced cerebrovascular reactivity, in part due to vascular oxidative stress), which precedes the
clinical onset of dementia. Lowering SBP with conventional pharmacotherapy decreases risk for MCI and
dementia; however, the vast majority of patients with CKD fail to achieve adequate BP control.
Boosting NAD+ bioavailability in mouse models of aging and AD improves risk factors for cognitive
impairment. In a pilot study, we found that boosting NAD+ via oral supplementation with nicotinamide
riboside reduced SBP and aortic stiffness in midlife and older adults, suggesting that nicotinamide riboside
supplementation improves multiple risk factors for mild cognitive impairment and AD. However, the
efficacy and underlying mechanisms of nicotinamide riboside for improving brain health in adults with CKD,
who are at high risk or MCI/dementia, are unknown but has been identified as high-priority research topics.
Leveraging our funded parent award clinical trial, we propose to assess the efficacy of oral nicotinamide
riboside to enhance brain health in adults with stage 3-4 CKD by adding measures of cognitive performance
and cerebrovascular function. To assess mechanisms of action, we also will use participant serum to
determine if the benefits of nicotinamide riboside supplementation are mediated by changes in circulating
metabolites that reduce mitochondrial ROS production in cerebrovascular endothelial cells (CECs).
Therefore, we are proposing to expand our parent award trial to include these clinical and mechanistic markers
of brain health in this high-risk population. This research is highly relevant to AD and related dementias
because it will evaluate a novel dietary supplement for improving cognitive function and established MCI/AD
risk factors in adults with stage 3-4 CKD. Leveraging an ongoing trial will stimulate research in the AD field by
allowing us to rapidly collect and disseminate results on the efficacy of dietary supplementation with
nicotinamide riboside for decreasing the risk for mild cognitive impairment, AD and related dementias in a
clinically-relevant, at-risk group. Thus, this administrative supplement will speed translation of a highly
promising intervention for preventing AD and related dementias in patients with moderate-to-severe CKD.

Public health relevance
PROJECT NARRATIVE Chronic kidney disease (CKD)-related increases in arterial stiffness and systolic blood pressure (SBP) are strong, independent cardiovascular risk factors for mild cognitive impairment, Alzheimer’s disease and related dementias. Nicotinamide riboside is a natural dietary supplement shown to decrease arterial stiffness and SBP and in humans and improve symptoms of Alzheimer’s disease and cerebrovascular function in rodents, in part through reducing oxidative stress. This administrative supplement seeks to establish the efficacy of nicotinamide riboside supplementation for improving cognitive and cerebrovascular functions and reducing oxidative stress in adults with CKD, who are at high risk of dementia.